Examining the impact of menstrual hygiene management on academic achievement and mental health outcomes among school-going adolescent girls in Uganda

Adolescent gir1s in low- and middle-income countries often face significant challenges related to menstrual
hygiene due to socio-economic constraints, cultural stigmatization, and lack of access to sanitary products.
Without access to adequate menstrual hygiene management (MHM) products, gir1s have no choice but to
resort to improvised and alternative methods for MHM, such as using leaves, cloth, or toilet paper. Moreover,
inadequate MHM has been linked to school absenteeism, highlighting its importance for the well-being of
adolescent gir1s. A study conducted by Miiro in Uganda showed that 19.8% of the gir1s in their study missed
school at least once during their last menstrual cycle, with 17.3% reporting school absenteeism specifically
during their menstrual day. These challenges significantly impact the educational outcomes and mental health
challenges of adolescents leading to stress, anxiety and psychological issues. Poverty is a key factor
hindering access of adolescent gir1s to sanitary pads (commercial products), potentially driving them to
engage in transactional sex to secure these essential hygiene items and maintain their education. The
proposed study will allow the candidate to: (1) acquire skills in mixed methods research and (2) gain a
comprehensive understanding of menstrual hygiene management practices, attitudes, and the contextual
factors that influence MHM practices, focusing particular1y on how they affect adolescent wellbeing, including
mental health functioning. This study therefore, examines the effects of menstrual hygiene practices on the
school attendance, academic performance, and mental health of adolescent gir1s in Southern Uganda, and
aims to identify the sociercultural factors that influence these practices.The study will utilize an exploratory
mixed-methods design integrating quantitative data from the Suubi4strongerFamilies project with qualitative
interviews to assess the impact of menstrual hygiene on girls' lives, and quantitatively, analyze the
relationship between Menstrual Hygiene management, mental health functioning and academic performance.
This study will contribute to a deeper understanding of the multi-faceted impacts of menstrual hygiene
management in Southern Uganda, aiming to inform targeted interventions and policy recommendations that
can enhance the educational and health prospects of adolescent gir1s. The anticipated results will be
instrumental for public health and education policy frameworks, contributing to the establishment of culturally
appropriate and economically viable menstrual hygiene management interventions that advance gender
equality and educational empowerment. Consistent with my training goals, the study will have the following
specific aims: (1) To assess how menstrual hygiene relates to school attendance rates, academic
achievement, and mental health among adolescent gir1s in Southern Uganda (Goal 1) and (2) To explore the
effects of sociercultural factors on menstrual hygiene, educational experiences, and mental health of
adolescent girls in Southern Uganda (Goal 2).

Public health relevance
This study will allow the candidate to acquire skills in mixed methods research and gain a comprehensive understanding of menstrual hygiene management practices, attitudes, and the contextual factors that influence MHM practices. Using an exploratory mixed-methods approach, the study will examine how cultural norms affect girls both mentally and physically, with implications for their school attendance and mental health. The findings aim to inform interventions and policies that can improve educational and mental health outcomes and break the cycle of menstrual challenges faced by school-going girls in Uganda.